Biomarkers for prognosis of closed-mechanism nerve injuries

ABSTRACT / PROJECT SUMMARY
Closed-mechanism peripheral nerve injuries are among the most devastating neurologic injuries, often with
complete loss of functional use of a limb. Nerve regeneration, i.e., the cascade of regenerative changes after
injury, commonly fails in rapid-stretch injuries. Instead, a neuroma forms – where abundant scar tissue replaces
the normal pathway for nerve regeneration. Unfortunately, in closed-mechanism injuries, there are few diagnostic
clues to identify when neuromas will form – and thus, clinical management is based on waiting until failure is
manifest – and the surgical outcomes are, consequentially, impoverished due to regenerative senescence.
The goal of this project is to test the hypotheses that there are biomarkers in peripheral blood to provide
prognosis and guide the management of closed mechanism nerve injuries. Neurological outcomes are clearly
related to the 1) severity of nerve injury and to 2) healing response, whether regeneration or neuroma formation.
We have established a rapid-stretch nerve injury model that mimics, along with crush injuries, the clinically
relevant closed-mechanism nerve injuries. Our model matches the injury types/grades and histology seen in
human nerve injuries. We propose utilizing both circulating protein and RNA molecules, to remain unbiased in
selecting the optimal diagnostic tool for the future. Machine learning algorithms will be applied to the large dataset
to improve diagnostic accuracy.
If successful, this project will provide preliminary data for designing future human trials aimed at evaluating nerve
injuries (R61/R33). Specifically, we will need to know whether proteomics or transcriptomics or a combination
will provide greater diagnostic accuracy, as well as developing workflow for machine learning algorithms. The
proposed evaluation will likely provide significant clinical utility in proximal nerve injuries, where the prognosis
for recovery is currently poor due to the prolonged time required to detect failed regeneration.

Public health relevance
PROJECT NARRATIVE Closed-mechanism nerve injuries are currently managed by expert opinion and leads to prolonged waiting, which is countervailing the biology of nerve regeneration. Substantial improvement can be made in neurological outcomes if there were assays to determine nerve injury severity and regeneration. We propose to identify biomarkers that are associated with outcomes so that nerve injuries can be diagnosed and treated optimally.